ANOREXIA, PROTEIN ENERGY MALNUTRITION AND CYTOKINES IN THE ELDERLY

To determine the relationship between 1) cytokines and anorexia, and 2) cytokines and protein energy malnutrition in elderly outpatients. The study will focus on certain cytokines associated with anorexia: interleukin 1 (IL-1), interleukin 6 (IL-6) and tumor necrosis factor (TNF).